Limited Competition: Continuation of the Center for Genomic Studies on Mental Disorders

Project Summary
The goal of the NIMH Repository and Genomics Resource (NRGR) is to further the understanding of the
genetic and environmental etiologies of mental disorders. The NRGR receives raw biosamples, such as blood,
from NIMH-supported research projects. The NRGR processes these samples to DNA, RNA, cDNA, or cell
lines, which can then be used for genomic analyses. The NRGR also receives, curates, and harmonizes
clinical/phenotypic data for each subject. Results of genomic analyses on samples in the NRGR are either
directly deposited in the NRGR or are linked to a deposit in another public repository. After a proprietary
period, the clinical data, genomic data, DNA, RNA, cDNA, and cell lines are made available to all NIMH-
approved researchers through a secure web portal. This sharing of uniformly processed biological samples
and curated clinical and genomic data from many cohorts leverages the NIMH investment in genetic studies. It
provides critical research power by making a very large body of data available for study of the genetic bases
for individual mental disorders. Since October 1998, >250K subject samples have been submitted to NRGR
and >615K DNA and >15K cell lines have been distributed. There have been >1,700 distributions of clinical
and genomic data to >1,000 investigators, resulting in >1,000 publications using NRGR samples and data.
Starting in 2011, the NRGR has provided in-depth characterization services for induced pluripotent stem cells
(iPSC) and their progenitor somatic cells, as well as limited iPSC production. As its guiding aim, the NRGR will
continue to innovate in order to serve the scientific needs of NIMH PIs in a flexible and highly accessible
manner, while respecting subject confidentiality, informed consent issues, and PI prerogatives.

Public health relevance
Project Narrative The NIMH Repository and Genomics Resource (NRGR) provides research resources that will enable scientists to identify the genetic causes of mental disorders. Understanding these genetic causes will likely result in new diagnostic and therapeutic approaches.